Integrative Analysis and Visualization Platform for Cancer Regulatory Genomics

PROJECT SUMMARY
Recent advancements in next-generation sequencing technologies have resulted in the generation of vast
quantities of publicly accessible data that are specific to cancer. This wealth of information has significantly
enhanced our comprehension of disease mechanisms. It is now evident that alterations in epigenetic and
genetic factors can disrupt the interactions between regulatory elements and their target genes, leading to
abnormal gene regulation. Numerous studies conducted on distinct cancer types have yielded promising
outcomes, unveiling previously unknown cancer subtypes characterized by distinctive enhancer landscapes.
Moreover, these studies have identified clinically relevant regulatory elements that have implications for
prognosis and treatment. Nevertheless, the majority of cancer analyses tend to concentrate on specific cancer
subtypes and fail to capitalize on the entire breadth of available data encompassing both tumorigenic and
normal tissue and cell types.
As members of the ENCODE project, we have created the Registry of candidate cis-Regulatory Elements, an
extensive compilation of nearly one million potential enhancers, promoters, and insulators in the human
genome. These elements have been characterized across over 800 human cell types, offering valuable
insights into non-coding regions. However, it's important to note that the Registry lacks clinical data, and all
experimental findings were obtained from healthy individuals, which limits its applicability in cancer research.
To address this limitation, we propose the development of a regulatory-element–target-gene atlas, which will
enable researchers to explore the connections between regulatory elements and genes associated with cancer
(Aim 1). Drawing upon our expertise in regulatory genomics and three-dimensional chromatin architecture, we
will perform extensive analysis to identify germline variants, somatic mutations, and other genetic aberrations
that affect cCREs and predict their effects on molecular phenotypes (Aim 2). Finally, to enhance accessibility
to these tools, we will establish a new cloud-based computational notebook-based environment equipped with
modular and customizable components for integrative data visualization. This environment will be flexible and
user-friendly, allowing researchers to easily access and utilize cancer-specific genomic data (Aim 3). Finally,
we will collaborate with ITCR members and perform community outreach (Aim 4).Together, these tools will
simplify and improve the accessibility of cancer-specific genomic data.

Public health relevance
NARRATIVE Our project focuses on developing a comprehensive platform to analyze and visualize cancer-specific regulatory genomics and chromatin structure, utilizing extensive genomic data from sources like TCGA, TARGET, and ICGC. This initiative includes creating a regulatory-element–target-gene atlas, identifying and predicting the effects of genetic aberrations on regulatory elements, and building an integrated, user-friendly web platform for data visualization and outreach within the scientific community.